PLACEBO CONTROLLED, DOSE-RANGING STUDY IN MODERATE TO SEVERE HYPERTENSION

The purpose of this study is to compare the effect of orally administered enacidil to placebo on blood pressure control during and at the end of a 12 hour dosing interval in adult patients with moderate-to-severe hypertension.